IGF::OT::IGF SCREENING AND ASSESSMENT RESOURCES; POP: 8/1/2014-7/31/2015; N43DA-14-5580

The purpose of this Phase I project is to design, develop, and evaluate the SAAR Program, our substance use and related risk behaviors screening and assessment system for providers and patients in healthcare service settings which will include web-based delivery of substance use risk assessments to patients and web-based delivery of the collected assessment data reports for providers based on these data.